Southern HIV and Alcohol Research Consortium Administrative and Research Support Core

The Southern HIV Alcohol Research Consortium (SHARC) was established in 2012 as one of five national
Consortia for HIV/AIDS and Alcohol Research Translation. The mission of SHARC is to improve health
outcomes and reduce HIV transmission in persons affected by alcohol and HIV in Florida. Florida has the
highest rate of new HIV infections in the US, a growing proportion of HIV+ persons over age 50, and broad
population diversity across age, gender, race/ethnicity, and geography (rural/urban).
The next phase of
SHARC (2016-2021)
will focus on the relationship of alcohol to HIV transmission (including HIV viral
suppression) and HIV comorbidities (especially brain function and liver disease).
SHARC will consist of three
integrated proposals that will: centralize our administrative and research infrastructure (this U24), determine
whether harmful aspects of alcohol on the brain are reversible (U01), and provide expertise in strategies to
change drinking behavior and in biostatistical analyses (U24). Specifically, this U24 proposal will
centralize SHARC administrative services, and also continue represents the
Administrative
the Florida Cohort study that
backbone of SHARC infrastructure and collaborative activity. The Cohort will be the source of participants for
our U01 research, and both the Cohort and U01 projects will be supported by the U24 behavioral/biostatistical
core. The specific aims of this U24 are Aim 1: E
nsure leadership, collaboration, and scientific oversight for all
activities related to SHARC. Specifically, the Core will:
obtain input from an Executive Committee, a Scientific
Advisory Board, and a Community Advisory Board; monitor our scientific contributions and research
productivity,
manage day-to-day operations, coordinate and facilitate requests to access SHARC data and/or
biological samples, provide IRB and regulatory support, and communicate our scientific findings. Aim 2:
Support ongoing collaborative research activity related to the Florida Cohort. The Cohort was initiated in 2014
and will complete enrollment of 1700 persons (1500 HIV+, 200 HIV-). Of these, 900 HIV+ will be tracked
prospectively using enhanced measures of alcohol consumption, neurocognition, liver disease, and HIV viral
suppression. These 900 will include 300 with heavy drinking (> 7 drinks/week women, >14 drinks/week men),
300 with moderate drinking, and 300 with no current drinking.
The Florida Cohort represents the backbone of
SHARC infrastructure that allows us to a)
engage in collaborative research that links public health settings and
academic institutions; b) support and expand our Training and Development Program; and c) facilitate
recruitment of participants into our companion U01 via a
participant contact registry
. The wide range of drinking
behavior and population diversity within the Cohort will allow
us to compare the impact of heavy drinking on
HIV outcomes across diverse populations and communities.
By partnering with at least 8 distinct public health
clinics and settings across the state, we are now poised to collaborate on a range of intervention and
implementation studies targeting individuals and public health clinics and settings.

Public health relevance
The mission of the Southern HIV Alcohol Research Consortium (SHARC) is to improve health outcomes and reduce HIV transmission among the diverse populations affected by alcohol and HIV in the Southeastern US. This Administrative Core will have direct public health relevance by providing the structured infrastructure, access to research participants and data, and research training needed to address this mission.